Pilot Project Program (P3)

Abstract Section
The overarching goal of the Enrichment & Research Administration Core (ERAC) is to support the scientific mission of the Dartmouth Cystic Fibrosis Research Center (DartCF): to foster an optimal environment for discovery of new principles of CF biology, epithelial function, gut microbial ecology, and host responses, and for their translation into clinical outcomes, in areas of interest to NIDDK. Launched in 2018, DartCF will continue to support three Biomedical Research Cores. It will deploy its pilot program to recruit new investigators and fund new research directions, including CF gut dysbiosis, GI microbial communities, kidney disease, and CFRD. It will also support an intensive research development program and will leverage institutional resources for program strengthening, including annual symposia and new training modules in best research practices. Working across the basic and translational spectrum, these components will advance the identification and validation of new therapeutic strategies in CF. Scientific leadership will be provided by Director Dean Madden, PhD, the DartCF leadership team, Internal and External Advisory Committees, and a Faculty Council reflecting all areas of expertise. The role of the ERAC is to provide efficient scientific leadership, organizational support, and fiscal oversight for all Center components. Building on strategies developed for other programmatic awards and deployed in the past six years of funding, the ERAC will achieve the following Specific Aims: (1) To provide scientific leadership supporting all DartCF members as they explore new high-impact research directions; (2) To support strategic research development opportunities; (3) To facilitate robust scientific communication; (4) To offer streamlined administrative and fiscal support, providing timely and accurate reporting to DartCF and institutional leadership and NIDDK Program staff; and (5) To enrich the scientific and research environment by deploying institutional resources. Each of these aims will advance the DartCF mission. Experienced leadership will identify and create new opportunities for Center faculty to pursue basic and translational research projects in CF, with a goal of improving therapeutic options and patient outcomes. The education program will provide expert guidance to our faculty, enhancing their research productivity and generating additional extramural support for CF research. A weekly research-in-progress series, interspersed with invited seminars and an annual Dartmouth CF Retreat, will support a highly interactive scientific community and stimulate the exploration of new research directions. Together with the Biomedical Research Cores, pilot and core funding will both recruit faculty to the Center and increase their ability to compete for extramural funding. Program leadership has a strong track record of scientific collaboration and two decades' experience with multi-project awards. Leveraging these skillsets, we have developed an Administrative Core committed to providing excellent organizational support to the investigators of DartCF and to advancing its success as an NIDDK-supported CF Research Center.